Establishing HIV/AIDS research in western Kenya

DESCRIPTION (provided by applicant): As in most of sub-Saharan Africa, the HIV/AIDS epidemic has had a major impact on nearly all aspects of life in Kenya. There are many barriers to controlling the epidemic, especially among people who reside in rural areas. We propose to begin to address this task by developing a comprehensive research program at the Moi University College of Health Sciences (MUCHS) in Eldoret, Kenya. Our goal is to identify the most pressing needs to combat the epidemic while developing the infrastructure to conduct basic and clinical research designed to provide viable approaches to controlling and preventing HIV/AIDS and its consequences among Kenyans and their society. To achieve this goal we will organize the foundations for a comprehensive, multidisciplinary HIV/AIDS basic and clinical Research Program with the establishment of Administrative, Clinical, Behavioral Science, Laboratory, Data and Informatics, and Developmental and Training Cores at MUCHS. We will prioritize HIV/AIDS prevention and care issues that may be readily studied within the context of the established CIPRA in anticipation of a submission of a U01 grant in 2005. Finally, we will develop an administrative structure at MUCHS to manage the budget and regulatory functions required to manage large NIH grants. This will be accomplished in a program that is led by Kenyan investigators working with partners from the Indiana University School of Medicine (IUSM), Brown University School of Medicine (BUSM), and the Aaron Diamond AIDS Research Center (ADARC).